Demographic Analysis on Determinants of Healthy Longevity in China

DESCRIPTION (provided by applicant): This is a resubmission of a competitive renewal R01 application to continue the research project Demographic Analysis on Determinants of Healthy Longevity in China (PI: Yi Zeng). We are requesting 5-year research support from 7/1/2010 to 6/30/2015, with substantial matching funds from Chinese resources. The goal of this proposed continuing R01 is to search for a better understanding of the effects of social, behavioral, and genetic factors and their interactions on healthy longevity. More specifically, we plan to achieve our goal through the following research activities. (1) Collect follow-up data on mortality and changes in health status in 2011 and 2014 for those 14,000 interviewees who contributed DNA samples for the first time in 2008. (2) Identify the healthy longevity related genes by genome-wide screening and genotyping with the two-stage study design of population association analysis as well as the convergent statistical analyses. (3) Innovatively apply advanced demographic/statistical methods to analyze the CLHLS multi-wave longitudinal survey data and genotype data produced by this project in an integrated way to estimate the impacts of environmental and genetic risk factors on health and longevity at old ages. In addition to studying the general associations between environmental and genetic factors, we plan to pay particular attention to analyze the effects of environment-gene interactions on healthy longevity. (4) Develop the genotypic and phenotypic database (including health conditions, disability status, behavior, life style, diet, psychological characteristics, survival and death, etc.). We will make this database of the world's largest sample of centenarians, nonagenarians, younger elderly, and middle-aged controls user-friendly and widely available to all interested scholars, while eliminating all information which may be potentially used to identify the individual participants.

Public health relevance
PUBLIC HEALTH RELEVANCE: This is the resubmission of the competitive renewal R01 application to continue the research project "Demographic Analysis on Determinants of Healthy Longevity in China" (PI: Yi Zeng), with substantial matching funds from Chinese resources. The goal of this proposed continuing R01 is to search for a better understanding of the effects of social, behavioral and genetic factors and their interactions on healthy longevity. We emphasize studying factors affecting health at old ages in the context of expanding lifespan, based on well-conducted interdisciplinary research. Project Narrative-Public Health Relevance This is the resubmission of the competitive renewal R01 application to continue the research project "Demographic Analysis on Determinants of Healthy Longevity in China" (PI: Yi Zeng), with substantial matching funds from Chinese resources. The goal of this proposed continuing R01 is to search for a better understanding of the effects of social, behavioral and genetic factors and their interactions on healthy longevity. We emphasize studying factors affecting health at old ages in the context of expanding lifespan, based on well-conducted interdisciplinary research. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS In general, we aim to substantially extend our current R01 into a new and innovative project through conducting interdisciplinary analysis based on the unprecedented, largest DNA samples in the world and more than 12-years of follow-up interview data from centenarians, nonagenarians, octogenarians and comparative younger groups with a high degree of genetic homogeneity as well as community data on the 943 diversified counties/cities where the interviewees live. The four innovative features of this renewal project can be summarized as follows: (1) fully utilize the potential strength of the largest collection of DNA samples to resolve the contradictions of previous research on candidate genes and their association with human health and longevity that has been especially hampered by small sample sizes of centenarians/nonagenarians in previous studies; (2) shift the healthy aging study paradigm from the purely individual level to a truly multilevel approach including social/behavioral factors at the individual level, socioeconomic and physical conditions at the community level, and genetics at the molecular level; we will innovatively conduct comparative analyses between seven longevity areas and the other sampled “ordinary” counties/cities; (3) emphasize the analysis of interaction effects between social, behavioral and genetic factors on healthy longevity, which has been very much under-investigated in both rich and poor countries; (4) create the world’s largest publicly available database of genotypes and phenotypes to support research on healthy aging while strictly protecting the confidentiality of participants. Aim 1. Collection of follow-up data on mortality and changes in health status in 2011 and 2014 for the 14,000 interviewees who first contributed DNA samples in the 2008-09 wave. While we will conduct cross-sectional analysis using the survey and genetic data already collected in the 2008-09 wave, we plan to use the follow-up data to be collected in the 2011 and 2014 waves to address scientific questions on the effects of social, behavioral and genetic factors and their interactions on mortality and morbidity at old ages. We expect that, among the elderly respondents interviewed in our 2008-09 wave, about 9,500 and 5,900 surviving elderly respondents will be re-interviewed in the 2011 and 2014 waves, respectively, based on anticipated mortality and loss-to-follow-up rates. We will also interview close family members of the approximately 6,600 and 4,095 respondents who die before the 2011 and 2014 waves, respectively, to collect data on date/cause of death and health/suffering status of the deceased respondents. Aim 2. Identification of the genes related to healthy longevity through genotyping and convergent statistical analyses (Innovation 1). We plan to employ a two-stage study design for population association analysis: (1) A first-stage genome-wide screening for 1,200 centenarians as cases and 1,200 controls aged 40-64. All of the 1,200 centenarian cases have at least one first-degree relative (parent or sibling) who survived to age 85 or older. All of the 1,200 middle-age controls have no first-degree relatives who survived to age 80. (2) A second-stage genotyping of statistically significant SNPs identified in the 1st stage for each of a new set of 4,000 individuals who are not screened in the 1st stage, including 2,000 centenarians and 2,000 middle-age controls aged 40-64. We will pool the genetic data produced in the 1st and 2nd stages, and integrate them with the corresponding phenotypic data on health and survival using a convergent statistical approach to identify new candidate genes related to healthy longevity. We will also confirm or refute the 35 candidate genes that have been reported to be associated with healthy longevity (see Section D5 for details), but often with contradictory evidence mainly due to small sample sizes (See Section B2.3). Aim 3. Interdisciplinary and integrated multilevel data analysis (Innovation 2-3). We propose using multiple specific and summary indices to measure different dimensions of healthy aging that are available in our CLHLS longitudinal data collected since 1998 (see Section D2 for details). Innovation 2 -- We aim to shift the paradigm of healthy aging studies from single-level to multi-level investigation by integrating social/behavior factors at both the individual and community levels collected in CLHLS and genotypic data at the molecular level to be produced by this project into a large database with a relatively high degree of genetic homogeneity. This will allow us to estimate the independent and joint impacts of social, behavioral and genetic risk factors on health and longevity at old ages. Innovation 3 -- We will particularly emphasize investigating the effects of interactions among social, behavioral and genetic factors (GxE) on healthy longevity. Based on our own and others’ prior research, we plan to test the hypotheses that (a) life stress triggers or exacerbates the effects of bad candidate gene(s) and thus harms health at old ages; (b) some candidate genes may positively or negatively affect (or even cause) elders’ resilience and positive emotions, which connotes the ability to bounce back from and cope with the negative events; or high resilience, happiness and harmonious family life may activate/strengthen the positive effects of good candidate genes and/or mitigate the negative effects of bad candidate genes, and thus have significant effects on the outcome of healthy longevity. (c) late-childbearing (after age 35-40) in women activates the good candidate genes and thus has a positive effect on healthy longevity; or some genes are positively (or negatively) associated with female fecundity after age 35, while childbearing after age 35 helps to stimulate biological systems and positively affect healthy longevity; (d) social/leisure/religious activities strengthen the effects of good candidate genes and/or mitigate the effects of bad candidate genes; (e) the bad (or good) candidate genes may exacerbate (or mitigate) the impacts of poor community conditions including low socioeconomic development level, environmental pollution, poor climate and geographic typology on health outcomes at old ages. We will develop and test more other GxE and gene-environment correlation (rGE) hypotheses as our research progresses and learning from newly emerging knowledge in the field (see Figure 1 for a general framework and Section D6.3 for detailed discussions). We also aim to make significant contributions to methodological development for interdisciplinary studies of interactions among social, behavioral and genetic factors, including (1) extension of the Fixed Attribute Dynamics (FAD) method published by Zeng and Vaupel (2004) to estimate the effects of combinations and interactions between social/behavioral factors and genotypes on long-term survival based on cohort or cross-sectional data; and (2) extension of novel analysis methods to evaluate heterogeneity in genetic analysis that is useful in evaluating and identifying genetically homogeneous subsets as well as addressing the potential of the gene-environment interactions by Hauser, who is one of the key investigators of this proposal, and her colleagues (Hauser, 2004; Qin at al., 2009; Schmidt, 2006). Aim 4. Multilevel genotypes and phenotypes data archiving (Innovation 4). We will develop the world’s largest multilevel database of genotypes and phenotypes (e.g., health outcome, disability, health behaviors, life style, family and social connections/support, diet, psychological characteristics, survival and death) for interviewees who are longitudinally interviewed, contribute DNA, and are genotyped. The longitudinal data collected from other CLHLS interviewees who did not contribute DNA samples will also be archived. The database will include community data on socioeconomic and physical environmental conditions in the diversified counties/cities where the respondents live. We will share the genotypic and the associated phenotypic data resulting from this project with researchers who are interested in using these data for scientific research, through placing the genotypic/phenotypic data at the NIH DbGaP GWAS data-sharing program and our ongoing CLHLS data-sharing programs at Duke, PKU, the University of Michigan and UCLA. Typically, the latest that this occurs is upon the acceptance of the publication of the articles using these genotypic/phenotypic data. As we have done in the existing CLHLS data-sharing programs, all of the information which may be potentially used to identify individuals (such as name, address, telephone number, geographical codes at township, county, district of city levels, etc.) will be eliminated in the genotypic/ phenotypic data to be shared with other researchers in order to strictly protect individual confidentiality. Half of the total costs of genetic analysis (Aim 2) will be covered by this grant and the other half will be covered by Chinese resources. About two-thirds of the total costs of the 2011 and 2014 follow-up surveys are requested in this proposal and another one-third will be covered by Chinese resources (Aim 1). The costs of integrated data analysis (Aim 3) and data archiving (Aim 4) will be covered by this grant.